Molecular investigations of HIV-1 maturation pathways and inhibitor actions in situ

PROJECT SUMMARY:
The HIV-1 life cycle critically depends on a maturation process that transforms the viral core from a spherical to
a conical shape, a crucial step for productive infection of host cells. This process is driven by the proteolytic
cleavage of Gag and Gag-Pol polyproteins, resulting in the formation of the mature capsid. Although significant
progress has been made in understanding Gag assembly and capsid structures, the dynamic transitions and
molecular mechanisms underlying HIV-1 maturation remain inadequately understood, particularly within native
cellular environments. To address these gaps, the Xiong laboratory has developed an advanced in situ cryo-
electron microscopy (cryo-EM) approach, enabling high-resolution visualization of these processes in their
native context. The research is structured around two specific aims: Aim 1 focuses on determining the high-
resolution structural pathway of HIV-1 Gag assemblies and capsid during maturation within their native
environment. This will involve using in situ cryo-EM and cryo-electron tomography (cryo-ET) to visualize the
complex structural transitions of HIV-1 Gag and capsid during maturation. These studies will be conducted on
both purified virus-like particles (VLPs) and budding viruses from infected cells, including clinically derived HIV-
1 isolates and primary CD4+ T cells. Preliminary data identify a novel hybrid capsid structure that may
represent a transitional state in HIV-1 maturation, supporting the hypothesis of a replacive maturation pathway.
This will be further tested through biochemical, structural, and functional experiments. Aim 2 will define the
mechanisms by which HIV-1 capsid cofactors and maturation inhibitors influence virus maturation during
budding. This will involve investigating how capsid inhibitors impact the maturation process using a
comprehensive experimental system, including in vitro assembled Gag constructs, purified VLPs, and budding
viruses on the cell surface. Preliminary findings have revealed new binding sites for Lenacapavir and a novel
cellular cofactor within the immature Gag lattice. The cellular cofactor will be thoroughly investigated to
determine its identity and function. The insights gained from this research will advance the understanding of
HIV-1 maturation, guide the development of new therapeutic strategies targeting the immature Gag structures
and the capsid, and provide valuable tools for studying host-virus interactions within their native cellular
environments.

Public health relevance
PROJECT NARRATIVE: HIV-1, the virus that causes AIDS, must undergo a critical maturation process, transforming its core structure to successfully infect human cells. Our research uses advanced imaging techniques to visualize this process within infected cells and to understand how certain drugs can block the virus from maturing. By gaining these insights, we hope to help improve treatments that prevent HIV-1 from becoming fully infectious.